Vironomics and Biostatistics Core

Core B: Vironomics and Biostatistics Core
Project Summary Abstract
This is a renewal application of a long-standing P01 grant. Core B provides Next Generation Sequencing,
bioinformatic and biostatistics capabilities that are specific to viral genomics and that are unique among US
investigators. It is used by all projects. Core B houses both physical instrument and specialized expertise, such
as dedicated Oxford Nanopore and Ion Torrent sequencers (S5 and Genexus), a BD Rhapsody single-cell
sequencing instrument, a project specific high-compute server and full-time programmer. This will ensure that
this long-standing VPP remains at the cutting edge in terms of technical innovation in tumor virology.

Public health relevance
Core B: Vironomics and Biostatistics Core Project Narrative Core B, Vironomics and Biostatistics, provides bioinformatics support for all projects and specializes in systems and high-throughput biology. Both analysis and “wet-lab” sequence generation are combined in one unit to maximize efficiency.